MIELHSS - Data Core

Data Core: Project Summary
The Massachusetts Institute for Equity-Focused Learning Health System Science (MIELHSS) brings together an
alliance of FQHCs, Safety Net Hospitals, Community Clinics, Patients, PCORnet sites, and leading academic
health systems who share a common purpose to accelerate research and train the future workforce to advance
learning health system science, address disparities, and improve health outcomes for the U.S. The Research
Data Core is central to the work of MIELHSS scholars, providing mentorship and support of their data needs and
focusing on AHRQ/PCORI priorities. The Research Core strives to further expand the impact of the Institute on
AHRQ/PCORI priorities around health equity by developing common data standards, shared practices, and an
infrastructure regarding equity data measures and social drivers of health across the MIELHSS Network.
Specifically, the goals of the Research Data Core are: 1) develop a shared federated data set of equity-focused
data measures and Social Drivers of Health (SDOH), 2) support cross-organizational research by establishing
mechanisms to compare data through distributed data analysis using a federated approach and 3) work with the
Administrative Core, Executive Committee, External Advisory Committee, mentors, and scholars to catalogue
and actively disseminate scientific information from MIELHSS across MIELHSS organizations, New England,
and the country to advance health equity.

Public health relevance
Research Data Core Narrative The Research Data Core (RDC) for the Massachusetts Institute for Equity-focused Learning Health System Science (MIELHSS) aims to support ongoing equity-focused research for and beyond the scholars by developing common data standards, shared practices, and an infrastructure for conducting distributed data analysis and data sharing across the MIELHSS organizations. We provide ongoing mentorship of MIELHSS scholars, assisting scholars in accessing and interpreting PCORnet, Medicare, Medicaid, and other research datasets, and we work in concert with the Administrative Core on dissemination strategies.